NJ ACTS: A Platform for Translational Science in New Jersey: CTSA Predoctoral T32 at Rutgers, Biomedical Health Sciences

The overarching goal of this T32 Predoctoral Training Program is to prepare future generations of translational
researchers to leverage the principles of translational science to identify, effectively disseminate, and
implement new approaches to address current health challenges. The objective of this training program is to
build upon the rich history of collaborative research and education among our alliance universities to develop a
personalized “precision” training program that instills in our early career biomedical researchers the knowledge,
skills, and abilities needed to effectively translate the information gleaned in the laboratory, clinic, and
community to real-world advances that improve health. All NJ ACTS Elements, Modules, and Workgroups will
provide services and platforms for training our T32 trainees and facilitate their nimble access to content and
method experts in a breadth of disciplines, including team science, informatics, biomarker discovery,
community engagement, health policy. Uniquely, ASCENT transcends the curriculum encountered in traditional
predoctoral programs by focusing on the knowledge and expertise needed to conduct translational team
research across disciplines while building social and leadership skills. Our Specific Aims are to: 1) Develop
the accessible and flexible ASCENT program with a focus on the precision training of predoctoral translational
researchers in the knowledge, skills and abilities needed to efficiently and effectively advance the diagnosis
and treatment of disease, modify behavior to prevent or reduce the impact of disease, and assure equity in the
research of disease and the access to healthcare; 2) Identify and recruit a cadre of outstanding translational
research and translational science faculty to act as Preceptors and instructors for our trainees and assure that
they have appropriate skills to be effective mentors for trainees with diverse scientific interest and
backgrounds, both during their time in the ASCENT program and as they transition to the next step of their
research careers; 3) Recruit and retain a diverse and exceptional cohort of trainees, committed to a career in
translational research and provide personalized training in the principles underlying each step along the
spectrum of translational research so they will complete the program with the knowledge, skills and abilities, as
well as the key characteristics, of a translational scientist; 4) Promote and assure a safe and inclusive learning
environment, where each trainee is respected as an individual, their learning is tailored to their previous and
current research interest, career aspirations, and personal situations, and where they recognize their role as
scientists to conduct and present their research with integrity, respect, clarity and transparency for the good of
society; and 5) Provide strong leadership, support and oversight, with comprehensive evaluation and
assessment of the faculty, students and programmatic activities, to assure that the ASCENT program fulfills
the mission and expectations of NCATs, the CTSA and NJ ACTS.

Public health relevance
The ASCENT T32 training program, under the auspices of the New Jersey Alliance for Clinical and Translational Science, is designed to provide predoctoral students from Rutgers University, Princeton University, and the New Jersey Institute of Technology a 2-year opportunity to increase their knowledge, skills, and abilities in translational science to prepare them for their careers in translational biomedical science.